Howard University Clinical Research Network for Health Equity

Research Abstract
African Americans experience significant disparities in chronic disease morbidity and mortality. Of note,
eliminating health disparities requires significant improvement in chronic disease management, which is
dependent on the provision and utilization of evidence-based preventive care. The provision of high-quality
preventive services to the African Americans is hindered by several things including insufficient evidence which
is a consequence of underrepresentation of minority populations in clinical research trials. In fact, United States
Preventive Services Task Force (USPSTF) recommendation statements often cite underrepresentation of
minorities in clinical trials as a research gap and limitation. This affects the development of clinical practice
guidelines that meet the needs of minority populations when the epidemiology of a particular disease is
different in minority populations. Not only is there an underrepresentation of minorities as study participants but
there is equally severe underrepresentation of African Americans as clinical investigators, which is due in part
to underrepresentation of African Americans in the clinical research workforce. Addressing these disparities
requires complex systems analysis, development of innovative approaches, generation of scientific evidence,
and effective knowledge dissemination. For over 150 years, Howard University has contributed significantly to
the African American physician workforce through undergraduate and graduate medical education. In addition,
Howard University has advanced minority health through robust research activities and comprehensive patient
care to the residents of the District of Columbia and beyond. The adoption of Electronic Medical Record
Systems by Howard University Hospital and Howard University Faculty Practice Plan has led to the generation
of vast amounts of clinical data about this inner-city urban low-income African American population.
To address the challenges, we propose the formation of the Howard University Clinical Research
Network (HUCRN) as an addition to the consortium of the RCMI Clinical Research Network for Health Equity
(RCMI-CRNHE). This effort will lead to an innovative, productive, and impactful research network for
investigation of studies of high importance in minority health and health disparities. The significance of this
project is derived from the necessity to study a health disparity affected population, burden of chronic disease,
prevalent health disparities, engagement of an underrepresented clinical research workforce. Further we intend
to introduce a new application of innovative data science called mHealth. We will develop a mHealth
information technology infrastructure, clinical research informatics infrastructure including a clinical data
repository, and we will conduct 2 pilot studies to assess the effectiveness of the infrastructure, policies, and
processes that have been implemented.

Public health relevance
Narrative Summary African Americans are not well represented in clinical research either as patients or investigators. The Howard University Clinical Research Network will develop, implement, and disseminate new technology to help recruit patients and health professionals to conduct research to improve minority health outcomes.